Novel regulatory networks driving human ribosome biogenesis

Project Summary/Abstract
Over the last 20 years there has been an explosion in the number of recognized human genetic diseases of
making ribosomes, the ribosomopathies, most of which are inherited, congenital conditions. Despite the clear
impact of abnormalities in ribosome biogenesis on human disease, ribosome biogenesis in human cells is just
beginning to be investigated and elucidated. Key challenges now are to pinpoint how ribosomes are made in
human cells, to define how this critical process is regulated in different tissues and in diverse cell types
throughout embryonic development, and to probe how failures in this process lead to the human diseases of
making ribosomes.
As one novel approach to better probe the mechanisms underlying how ribosomes are made in human cells,
we have successfully developed a unique, highly-quantitative and image-based cellular assay that reports
nucleolar dysfunction (Cell Reports 2018; PLoS Genetics 2020; Molecular Biology of the Cell 2021; RNA
2022). We have conducted a genome-wide siRNA screen in near-diploid MCF10A human breast epithelial
cells to identify cellular proteins that change nucleolar number. This screen was the first RNAi campaign to use
nucleolar number as an endpoint, and the first screen of its type carried out in a human cell line other than
Hela cells. This unbiased screening approach revealed many new cellular proteins (the “hits”) not previously
connected to making ribosomes. Extending this work to non-coding RNAs, we have now applied our robust
screening assay to systematically identify microRNAs whose overexpression inhibits ribosome biogenesis, and
we are currently probing their mRNA targets and mechanisms of action.
From the genome-wide siRNA screen we have obtained and successfully validated both nucleolar and non-
nucleolar hits, prompting the hypothesis that the non-nucleolar proteins are novel indirect regulators of
ribosome biogenesis in human cells. With tailored technological strategies, we will further define the role of a
subset of the hits in ribosome biogenesis in human tissue culture cells, shedding light on unique regulatory
pathways. In addition, we will link a subset of them to a critical requirement in embryonic development using
Xenopus tropicalis as a model system. Once looked upon as a “housekeeping” organelle, our work will
highlight the nucleolus as a significant contributor to human genetic disease and congenital malformations.

Public health relevance
Project Narrative This proposal is designed to answer important questions about the connections between making ribosomes and human disease. Ribosomes are the cellular factories that synthesize proteins in all human cells. As both cancer and genetic diseases of newborn babies are linked to abnormalities in the making of ribosomes, our work will be crucial for elucidating the underlying mechanisms of these diseases.